Cyclic nucleotide phosphodiesterase regulation in vascular calcification

,. ,$ ' ' $!$ .$*) , -/'.- !,*( .# +*-$.$*) *! ' $/( #3 ,*23 + .$. ,3-. '- $) .# 0 -- ' 1 '' . $- #$"#'3
+, 0 ' ). $) + .$ ).- 1$.# #,*)$ &$ ) 3 $- - ) $ . - - 1 '' - .#*- 1$.# + ,$+# , ' ,. ,3
$- - # ) '* . $) .# ,. ,$ ' ( $ ' $!$ .$*) $- -.,*)"'3 --* $ . 1$.# $) , -
, $*0 - /' , (*, $ $.3 ) (*,. '$.3 ' $!$ .$*) $- #$"#'3 , "/' . +,* -- *).,*'' 3 - ,$ - *!
) *" )*/- -.$(/' .*,- ) $)#$ $.*,- ' 0 . +#*-+# . ' 0 '- ) $) / *-. *" )$ ., )-!*,( .$*) *!
0 - /' , -(**.# (/- ' ''- - # - ''- , ' - 2., ''/' , ( .,$2 ", $)" )43( - $) '/ $)"
.# ( .,$2 ( . ''*+,*. $) - - - .# . *).,$ /. .* ' $!$ .$*) -+$. -$")$!$ ). +,*", -- ,. ,$ '
' $!$ .$*) *).$)/ - .* +**,'3 /) ,-.** ) )* /- ' ,/"- .* +, 0 ). *, ., . $. # 0 ) 0 '*+
*, .#$- , -*) .# +,* -- *! $ ).$!3$)" )*0 ' (*' /' , . ," .- ) 0 '*+$)" .# , +$ - .* . ," . .# ( ,
,$.$ ' !*, $(+,*0$)" */. *( - $) */, 0 - /' , + .$ ).- # - *) ( -- )" , 3 '$ )/ ' *.$ - )
+' 3 $(+*,. ). , "/' .*,3 ,*' - $) 0 ,$ .3 *! #/( ) $- - - .# . , *).,*'' 3 $-.$) . 3 '$
)/ ' *.$ $-*43( - .# . # 0 +,*0 ) .* $ ' ) ! -$ ' ,/" . ," .- !*, .# ., .( ). *! #/( )
$- - - # !/) .$*) ) , "/' .$*) *! - $) ,. ,$ ' ' $!$ .$*) #*1 0 , , ( $)- /)&)*1) #$-
+,*+*- ' $- - *) */, +, '$($) ,3 . -#*1$)" .# . +#*-+#* $ -. , - $- .# (*-. #$"#'3
$) / $-*!*,( (*)" '' " ) - $) ,* ). ' $!$ .$*) (* ' $- '-* ( ,& '3 $) , - $)
' $!3$)" - ' $!$ ,. ,$ - ) ' $!$ #/( ) .$ $ ' ,. ,$ - !,*( + .$ ).- 1$.#
)* & *1) ) $)#$ $.$*) *! -$")$!$ ).'3 .. )/ . +#*-+# . $) / *-. *" )$
., )-!*,( .$*) ) ' $!$ .$*) ) !$ $ ) 3 *! , / - ,. ,$ ' ' $!$ .$*) -$)"
$*$)!*,( .$ - ) '3- - ) '*-- *! !/) .$*) -., . "3 1 # 0 -#*1) .# . .# ! ($'3 ( ( ,
-.,*( '3-$) ) , "/' . 3 $) - /'./, $) ' $!$ .$*) ( $/( /, !/,.# ,
+, '$($) ,3 ( # )$-.$ , -/'.- # 0 -#*1) .# . *.# &)* & *1) ) $)#$ $.$*) *! '* & +
.$0 .$*) $) - /,$)" ' $!$ .$*) # 0 $.$*) ''3 !*/) .# . $)#$ $.$*) *! + .. )/ . -
/+, "/' .$*) /) , ' $!3$)" *) $.$*)- ) .#$- +,*% . 1 +,*+*- .# . ( $ . - ,. ,$ '
' $!$ .$*) 3 , "/' .$)" + -$") '$)" ) .#$- - ,$ - *! 2+ ,$( ).- 1 1$'' -. '$-# .# ,*'
*! $) ,. ,$ ' ' $!$ .$*) ) +,*0$ $)-$"#.- $).* .# +*. ).$ ' /- *! $)#$ $.$*) -., . "$ - .*
, / ' $!$ .$*) $) + .$ ).- 1$.# ) /, $(- , .* $)0 -.$" . .# .$*)- *! $)
0 - /' , *-. *" )$ ., )-!*,( .$*) ) ,. ,$ ' ' $!$ .$*) 2 ($) .# .# , + /.$ +*. ).$ ' *!
$)#$ $.$*) $) ,. ,$ ' ' $!$ .$*) ) -- -- .# -$")$!$ ) *! + -$") '$)" $)
( $ . 0 - /' , ' $!$ .$*)

Public health relevance
PROJECT NARRATIVE Calcification that develops in leg arteries of patients with diabetes, chronic kidney disease, and peripheral artery disease is strongly associated with increased cardiovascular morbidity and mortality. This proposal seeks to demonstrate that a specific enzyme, the phosphodiesterase 10A (PDE10A), plays a crucial role in vascular calcification by regulating p38-MAPK-MMP-3 signaling. Our goal is to target PDE10A as a novel therapeutic strategy to reduce medial artery calcification and prevent amputation in our patients.